Boost: A pragmatic inpatient rehabilitation strategy for improving musculoskeletal arm recovery after stroke

One in six people will have a stroke; over half will incur chronic upper extremity (UE) impairment. While
intensive rehabilitation reduces impairment, most individuals do not perform enough movement practice
early after stroke when plasticity is heightened. Our hypothesis is that there is a threshold level of UE
motor drive needed to provoke true UE recovery, yet individuals do not routinely exceed this threshold
during inpatient rehabilitation. To solve this, Flint Rehab and UC Irvine propose to test a novel, pragmatic
rehabilitation strategy for enabling individuals with even severe arm impairment to increase UE motor
drive early after stroke. We will leverage a ubiquitous piece of technology–the manual wheelchair–based
on two key observations. The first is a pivotal study by Feys et al. that had 100 inpatients with subacute
stroke rock themselves in rocking chairs by repetitively reaching forward with their impaired arm 500-
1000 times per day; these patients had significantly greater increases in UE Fugl-Meyer (FM) score of 17
points at a five-year follow up compared to control. This is a remarkable effect, yet this therapy remains
unimplemented in routine clinical practice. A second observation: 70% of stroke inpatients (and nearly all
with more severe impairments) spend several hours each day sitting passively in manual wheelchairs,
often with their paretic arm strapped into an arm trough. Further, when they move in their wheelchair,
they are pushed, or taught to use their “good” arm and leg. Our core idea is to use a novel, moveable
wheelchair armrest called Boost to enable inpatients to perform the repetitive arm therapy validated by
Feys while seated in their wheelchair. Boost quickly clicks into a wheelchair frame just like a conventional
wheelchair armrest and incorporates an innovative linear mechanism that enables UE activation in two
modes: 1) with the chair remaining stationary, or 2) with the user contributing to propelling their
wheelchair with their impaired arm. This latter mode transforms the "good arm + good leg" compensatory
wheelchair propulsion technique into “good arm + good leg + impaired arm” propulsion. We hypothesize
that use of Boost during inpatient therapy will enable individuals with stroke to achieve the threshold
level of UE motor drive required to provoke UE recovery in routine practice, significantly improving
recovery compared to conventional treatment. We have already pilot tested a functional prototype of
Boost with positive results. Thus, for this Direct-to-Phase II SBIR our aims are to: Aim 1) Develop a
commercial-ready model of Boost with clinical and end-user feedback; Aim 2) Perform a randomized
controlled trial of Boost with inpatients with subacute stroke (N=58). At project end, we will have
validated the clinical feasibility and efficacy of Boost and optimized it for production and mass distribution.
If our plan is successful, we will have demonstrated that wheelchair-based “rocking therapy” can help
patients routinely achieve the threshold level of sensory motor drive needed to provoke true UE recovery.

Public health relevance
This research is relevant to public health because it will increase accessibility to beneﬁcial rehabilita�on therapy for individuals with more severe motor deﬁcits. This will provide a pathway to a be�er life for millions of US ci�zens suﬀering from upper extremity motor impairment a�er stroke and other neurologic injuries. Not only does rehabilita�on therapy reduce the likelihood of devasta�ng complica�ons, it also improves func�onal ability, increasing the standard of living of individuals with impairment and reducing the burden on society caused by disability.